Structure and Function of Lens Membrane Proteins

DESCRIPTION (provided by applicant): The ocular lens is a unique structure exquisitely designed to focus light onto the retina, a process that requires substantial shape changes of the lens according to the distance of the eye from the object it is focusing on. To accomplish its function, the lens also has to be transparent, and it has to provide a high index of refraction. We are interested in the structure and function of membrane proteins in the lens, which play crucial roles in maintaining lens homeostasis and transparency. A highly specialized array of membrane channels and transporters is the basis for a microcirculation system that supplies deeper-lying fiber cells with nutrients and clears them of waste products. Moreover, membrane proteins mediate the tight packing of the fiber cells, thus reducing spaces between cells to a distance smaller than the wavelength of light, an important prerequisite to avoid light scattering by the lens tissue. This proposal focuses on the two major membrane proteins found in lens fiber cells, the tetraspanin MP20 and the aquaglyceroporin MIP (also referred to as aquaporin-0). Mutations in either one of these two membrane proteins lead to the formation of cataracts, demonstrating their importance for proper lens function. Structural information on MP20 as well as other tetraspanins is still sparse. Specific Aim 1 is thus to determine the structure of MP20 primarily by electron microscopy but also pursuing an X-ray crystallographic approach. The structural information obtained for MP20 will be useful to model the structure of other members of the tetraspanin family, which are important in many cellular processes, such as cell adhesion, proliferation, activation, migration, and apoptosis. Specific Aim 2 is directed towards characterizing the function of MP20 as a cell adhesion molecule by further studies of its interaction with galectin-3, a prominent adhesion modulator. We will also determine whether MP20 can bind to lens-specific integrins, as many tetraspanins are known to interact with integrins, especially if these contain a b1 subunit. The function of MIP as a pore for water and small uncharged molecules is well characterized, but unlike other aquaporins MIP also has adhesive properties and can form intercellular junctions, possibly creating continuous water pores between fiber cells. The objective of Specific Aim 3 is to create a pseudo-atomic model for the MIP-mediated membrane junction using a combination of X-ray and electron crystallography. The structure of the membrane junction will reveal the arrangement of the water pores in interacting MIP tetramers, which has important implications for the functioning of the microcirculation system in the lens.